Controlled Trial of Game Changers: A Group Intervention to Train HIV Clients to be Change Agents for HIV Prevention in Uganda

ABSTRACT
In Uganda, 1.5 million individuals are living with HIV where there are persistent gaps in the HIV care continuum
and prevention efforts. Barriers such as government funding and political and cultural challenges, have
impeded HIV prevention and have led to projections of rapid increases in HIV incidence. HIV prevention
advocacy efforts in which people living with HIV (PLWH) initiate conversations about HIV and provide HIV
prevention information to people in their social networks can be a low-cost approach to addressing the
epidemic. The assessment of social networks in the context of HIV research to date has been cross-sectional,
yet network relationships and memberships are dynamic in that they change over the life course, potentially
impacting HIV behavior over the time. Thus, using data from the parent study, the proposed supplement seeks
to further understand how, when, and why social networks change over time and their impact on HIV
prevention behavior and outcomes. The specific aims are: 1) To examine cross-sectional associations between
HIV-related outcomes on the part of index PLWH participants (ART adherence, condomless sex, viral
suppression among index participants) with individual-level factors (socio-demographic characteristics, social
roles, internalized HIV stigma), dyadic-level relational factors (trust, frequency of contact, HIV disclosure, and
HIV prevention advocacy with alters), social network composition (e.g., proportion of alters who are
stigmatizing, proportion of alters who use PrEP, proportion of alters who are tested for HIV) and network
structure (e.g., density or connections among alters) among the PLWH index participants; and 2) To explore
longitudinally, over 12 months, how changes in HIV-related outcomes, individual-level factors, and dyadic-level
factors change in conjunction with changes in social network composition (e.g., reduced proportion of alters
who are stigmatizing, increased proportion who use PrEP and are tested) and structure (e.g., increased
density) over time among the PLWH index participants. The proposed supplement study will use data from the
parent study’s first 100 PLWH participants and their alters (approximately 300) at baseline and 6- and 12-
month follow-up. We will examine cross-sectional associations of network structure and composition with
individual- and dyadic-level factors using bivariate cross-tabulations, and regressions using a feature detection
approach. Latent growth models (LGM), parallel process LGM and auto-logistic actor attribute models will be
used to assess how the network system impacts HIV outcomes longitudinally. This study could greatly aid
ongoing efforts to reduce HIV incidence by providing a deeper understanding of the effects of social network
dynamics on HIV outcomes across time.

Public health relevance
PROJECT NARRATIVE: Using data from the parent study, the proposed supplement will expand current research to assess how HIV outcomes among people living with HIV (ART adherence, condomless sex, viral suppression), individual-level factors (e.g., internalized HIV stigma), and interpersonal factors (e.g., stigma from social network members) change in conjunction with changes in social network composition and structure over time. This research study will contribute to the literature that informs the evaluation (and stability) of social network intervention effects (e.g., how interventions may change the structure of social networks), as well as the assessment of the impact of social network change on HIV outcomes.